Serotonergic regulation of social function following early life adversity

ABSTRACT
Early life experience is critical in shaping the circuits that underlie adult behavior, and adversity or
deprivation early in life robustly increases the risk for development of numerous neuropsychiatric
disorders. In this project, we will investigate the role of serotonergic neurons in alterations in adult
social behavior following early life adversity. Here, we will use the limited bedding and nesting model
of early life adversity in mice to understand links between early experience, the serotonergic system,
and social competition in dominance tasks. We will take a multidisciplinary approach, utilizing
electrophysiology, behavioral assays, and fiber photometry to address the hypothesis that early life
adversity leads to reduced excitability of serotonergic neurons and alterations in social dominance
processing. In the first aim, we will examine the effect of bidirectionally modulating the activity of
serotonergic neurons on social competition in adult mice who experienced early life stress. In the
second, we will use fiber photometry to investigate early life adversity-induced alterations in
serotonergic dynamics during competitive social behavior. These studies hold the potential to
contribute significantly to our understanding of how the serotonergic system is altered by early life
experience and may lead to novel avenues for the development of therapeutics for social symptoms
of neuropsychiatric illnesses.

Public health relevance
PROJECT NARRATIVE Social decision making is a process essential for both survival and well-being across animal species and disruptions in social processing are a common feature of numerous neuropsychiatric disorders. Studies defining how early adverse experiences alter circuits encoding social stimuli and decision making will be important steps towards identifying novel treatments for these disorders. This study will focus on the role of serotonergic signaling in alterations in social dominance processing following early life adversity.